New X-ray Diffractometer and Detector for Purdue Macromolecular Crystallography

Summary
Macromolecular structure determination at atomic resolution via X-ray crystallography is arguably one of the
greatest technical achievements in the life sciences over the last century. By shedding light on molecular
mechanisms essential for life, the technique has dramatically deepened our understanding of health and disease
and accelerated the development of drugs that are more selective, potent, and safe. The story of protein
crystallography at Purdue began in 1964 with the recruitment of Michael Rossmann, a pioneer in the field. A
formal biophysics training program was instituted in 1989 with an NRSA Institutional Predoctoral Training Grant,
coinciding with the award of a multi-million dollar Markey Foundation grant, which provided funds for hiring
additional faculty and the X-ray generators currently in the existing X-ray facility. Armed with excellent facilities
and expert faculty dedicated to advancing molecular biophysics and the training of junior scientists, Purdue
produced many successful investigators including Hao Wu (Harvard), Liang Tong (Columbia), Marvin Hackert
(UT Austin), and Jack Johnson (Scripps). John Tesmer, the PI of this proposal, is likewise a Purdue trainee.
Purdue has also served as an important hub for innovation in the field. For example, Dr. Rossmann and Dr.
Janet Smith were key contributors to the techniques of molecular replacement and MAD phasing, respectively,
which are now the two most commonly used phasing techniques world-wide. A new era in Purdue structural
biology has begun. In 2009, the university opened Hockmeyer Hall of Structural Biology, a 30 million dollar facility
and the new home of the Macromolecular Crystallography core. Purdue reaffirmed its commitment to structural
biology by updating the core with the 2019 purchase of a RockImager Duo crystal hotel and imaging system,
and an Oxford Cryosystems 800 Series liquid nitrogen cooler. A reboot of our T32 Molecular Biophysics Training
Program (funded 2019-24) now supports 7 trainees per year (Tesmer PI). The specific aim of this proposal is to
fulfill a critical need by replacing our aging ~30 year old X-ray generators, which can no longer be repaired, with
a modern, reliable, and cost effective MicroMax-007 HF rotating anode generator coupled to a synchrotron
quality, Dectris Eiger2 hybrid photon counting detector. The generator and its advanced optics will provide a
brilliant, small 90 µm X-ray beam at the crystal, optimizing signal-to-noise for small samples. The large 155x163
mm detector will be ideal for weak reflections, with small 75 µm pixels to resolve closely spaced reflections. A 4-
circle kappa goniometer will add flexibility in data collection. The new setup will improve X-ray flux >100-fold,
and the detector sensitivity is about 10 times greater than imaging plates, thereby improving our overall
performance by about three orders of magnitude and enabling the collection of superior diffraction data from
even the most challenging crystals. The new configuration will greatly benefit the scientific and educational
mission of at least 20 faculty by not only providing high resolution biological insights into their targets, but also
accelerating the development of novel therapeutics targeting cancer and neurological disease.

Public health relevance
Narrative Since the late 1960s, X-ray crystallographers at Purdue University have brought to light atomic structures of macromolecules important to human health and have served as a hub of innovation. However, the two X-ray systems currently supporting over 20 investigators at Purdue are 27 and 30 years old, and so outdated that they have very limited or no parts support from the manufacturers, thus putting us only two major failures away from becoming non-functional. This proposal concerns the purchase of a Rigaku Synergy Custom system, with a reliable, cost effective Rigaku MicroMax-007 HF rotating anode generator, coupled with a high brilliance, very small beam VariMax VHF Arc)Sec optic, and a synchrotron quality, Dectris Eiger2 R 4M hybrid photon counting (HPC) detector, all of which will dramatically enhance our ability to accurately assess and measure weak diffraction maxima from challenging small crystal samples and train future structural biologists in our home facility for decades to come.